Molecular Mechanisms of Staphylococcus Epidermidis Strain Diversity

PROJECT SUMMARY / ABSTRACT
Staphylococcus epidermidis is a ubiquitous member of the human skin and mucosal microbiota. Functionally, it
is a key contributor to human health via immune modulation and microbial community homeostasis. Yet the
‘commensal’ S. epidermidis is also an important pathogen and disease risk reservoir—it is the most frequent
cause of medical device and bloodstream infections. Multiple phylogenetically diverse subspecies, or strains,
of S. epidermidis can co-inhabit the skin with genomes of variable gene content. The overwhelming majority of
these genes have unknown function. We hypothesize that this variable gene content, or accessory genome,
interacts with core genes to enable strains to uniquely respond to and thrive in different environments, and that
mixing of these genetically diverse strains is necessary to maintain a healthy homeostasis in the skin. To
investigate the function of these genes and to understand how genetic diversity at the strain level contributes to
population-level phenotype, we will functionally profile a set of phylogenetically diverse strains isolated from
healthy individuals and individuals with bloodstream infections. We will create CRISPRi tools for gene
knockdown in S. epidermidis to systematically identify strain-specific and core genes that underlie the ability to
colonize and compete in the skin and infections. Aim 1 develops the CRISPRi genetic toolkit to created pooled
S. epidermidis knockdown pools. Phenotypic profiling these pools will greatly expand our knowledge of
important commensal strategies employed by a common microbial partner, and how genetic heterogeneity
may impact the commensal to infectious transition. Aim 2 investigates the role of strain admixture in this
transition. This combination of genomic approaches and mechanistic studies will provide the first investigation
into the function of the S. epidermidis pangenome. Annotating inter-strain genetic diversity will reveal new
insights into the functional consequence of strain diversity: how strains can successfully transition between
commensal and virulence lifestyles, and how multiple strains can co-exist in an ecological network.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Staphylococcus epidermidis is a bacteria that broadly inhabits healthy human skin, yet it is also a common cause of skin infections and bloodstream infections associated with implanted medical devices. Because human skin has many different types of S. epidermidis, each containing different genes, our goal is to determine how these different genes allow S. epidermidis to switch from healthy growth in the skin to being an infectious pathogen. Understanding this switch is critical to developing new strategies to prevent and treat infections from S. epidermidis.